Chicago Center for Diabetes Translation Research

PROJECT SUMMARY - Overall
The Chicago Center for Diabetes Translation Research aims to expand its role as one of the pioneering
national leaders investigating how to translate diabetes research findings into real-world practice, with an
emphasis on reducing racial/ethnic and socioeconomic disparities in health. We combine the complementary
strengths of University of Chicago and Northwestern University, as well as numerous partners and
stakeholders, into a city-wide center to amplify our CDTR's impact on Chicago, the Midwest region, and nation.
The Chicago CDTR is comprised of 3 Translational Research Method Cores (Intervention Design and
Implementation Science; Research Design, Data, and Analytics; Community Engagement and Health Equity);
an Enrichment Program that combines an exciting mix of seminars, guest speakers, visiting scientists,
consultants, and workshops to improve research knowledge and skills and advance the careers of new
investigators; and a Pilot & Feasibility Program that supports innovative diabetes research that aims to
translate scientific findings into real-world practice. Our Center will have 6 Working Groups to facilitate
collaborative research. We also propose an innovative and high impact National Resource Core named
“Accelerating Health Equity And Eliminating Diabetes Disparities in Community Health Centers
(AHEAD-CHC)”.
Our Center's Specific Aims are:
1. To provide core resources in Intervention Design and Implementation Science; Research Design, Data, and
Analytics; Community Engagement and Health Equity; Accelerating Health Equity And Eliminating Diabetes
Disparities in Community Health Centers (AHEAD-CHC) that catalyze and support innovative, rigorous
translational research to advance health equity for the prevention and management of diabetes.
2. To increase the impact of rigorous diabetes translational research to reduce disparities in Chicago and the
nation by organizing partnerships across academic institutions and stakeholder groups into working groups
that include: Clinician-Patient Relationship and Shared Decision Making, Social Determinants of Health,
Diabetes Prevention, Diabetes Modeling, Organization and Financing of Care, Diabetes and Aging.
3. To attract and support diverse investigators who are new to the area of diabetes translational research by
providing education, training, mentoring, support for community and stakeholder engagement, pilot and
feasibility seed grants, and access to critical translational research core resources.

Public health relevance
PROJECT NARRATIVE Jointly led by the University of Chicago and Northwestern University, the Chicago Center for Diabetes Translation Research (CCDTR) will provide core resources in Intervention Design and Implementation Science; Research Design, Data, and Analytics; Community Engagement and Health Equity; and Accelerating Health Equity And Eliminating Diabetes Disparities in Community Health Centers (AHEAD-CHC) that catalyze and support innovative and rigorous translational research to advance health equity for the prevention and management of diabetes. The CCDTR will increase the impact of rigorous diabetes translational research to reduce disparities in Chicago and the nation by organizing partnerships across academic institutions and stakeholder groups into working groups that include: Clinician-Patient Relationship and Shared Decision Making, Social Determinants of Health, Diabetes Prevention, Diabetes Modeling, Organization and Financing of Care (focusing in Community Health Centers and Medicaid), Diabetes and Aging. The CCDTR will attract and support diverse investigators who are new to the area of diabetes translational research by providing education, training, mentoring, support for community and stakeholder engagement, pilot and feasibility seed grants, and access to critical translational research core resources.